Visible-to-near-infrared spanning Optical Coherence Tomography for retinal imaging at the half-micron scale

Abstract:
Historically there have been no effective treatments for geographic atrophy, the end stage of dry age-related
macular degeneration (AMD). Recently, two complement inhibition treatments were shown to slow atrophic AMD
progression, leading to FDA approval last year. Ideally, these and other promising treatments would be applied
even earlier, before atrophy has begun. In this endeavor, early, high-risk biomarkers are needed. While the
Classification of Atrophy Meetings (CAM) scheme provides staging of atrophy and nascent atrophy, it lacks
granularity in the intermediate AMD stage, when these and other treatments are likely to be most effective.
Macular pigments (MPs) and retinal pigment epithelium (RPE) melanosomes are beneficial for vision and protect
against the development of advanced AMD. MPs are the target of Age-Related Eye Disease Study
(AREDS)/AREDS2 dietary supplements, and until recently, the only accepted intervention for dry AMD.
However, accurate measurement of MPs in the living eye has been challenging, and for this reason large-scale
MP assessment was omitted from the landmark AREDS/AREDS2 studies. Likewise, there is no accepted
method to measure RPE melanosomes/melanolipofuscin (RPEMs) in humans, so the CAM scheme assesses
RPEM loss indirectly, by OCT hyper-transmission.
Over the past several years, our group has pushed the axial resolution of visible light Optical Coherence
Tomography (OCT) to 1 micrometer, demonstrating a multitude of bands which are not quantifiable by other
techniques, including important substrates of AMD within the photoreceptors, retinal pigment epithelium (RPE),
and Bruch's membrane (BM). Recently we showed quantification and localization of MPs to Henle's fiber layer
for the first time in vivo, along with preliminary data showing the ability to distinguish lutein and zeaxanthin, the
two major MPs. We also demonstrated direct RPEM imaging in vivo via a new spectral red-shift technique.
In this proposal, the utility of the above advances for studying aging and AMD will be further bolstered with finer
axial resolution and broader spectral coverage. Specifically, we will develop visible-to-near-infrared spanning
OCT to image depth-resolved MPs, RPEMs and other novel outer retinal structural biomarkers for the first time,
with up to 0.5 micrometer axial resolution, ~6x finer than the best commercial NIR OCT systems (Aim 1). We
will investigate the spatiotemporal relationship of these biomarkers with aging (Aim 2) and early AMD (Aim 3a).
Finally, we will determine whether MPs and RPEMs (or lack thereof) could serve as early biomarkers for risk of
progression to atrophy, by determining association with other high-risk biomarkers (Aim 3b). If borne out by
subsequent longitudinal studies, visible light OCT assessment of retinal morphology and MPs/RPEMs could
identify potential beneficiaries of early dry AMD treatment.

Public health relevance
Project Narrative: Here we propose a substantive step forward in human retinal imaging technology: visible-to-near-infrared spanning Optical Coherence Tomography, with an unprecedented level of resolution. Besides imaging the retina with ultrafine resolution, this advance will enable localizing and measuring protective macular pigments and melanosomes/melanolipofuscin in the living human retina. With this new tool in hand, we will investigate changes in aging and age-related macular degeneration (AMD), in order to facilitate earlier diagnosis of AMD progression to enable more rapid adoption of vision sparing treatments.